Administrative Coordinating Center: Bench to Bassinet Program

Project Abstract
Research for patients with congenital heart disease requires a cooperative and coordinated
effort among research programs to efficiently translate results from basic science to clinical
research, and to provide clinical input on pressing needs for basic research. Our proposed ACC
to support the PCGC and CDDRC is a unique, integrated combination of world-leading pediatric
cardiovascular clinical/translational research expertise, advanced infrastructure, outstanding
institutional support, and state-of-the-art technology.

Public health relevance
Project Narrative The NHLBI’s Bench to Bassinet Program (B2B) was launched to accelerate pediatric cardiovascular translational research from discovery to early translational testing to clinical testing. The B2B is comprised of the Pediatric Cardiac Genomics Consortium (PCGC), the Cardiovascular Developmental Biology Data Resource Center (CDDRC), and the Pediatric Heart Network (PHN). Objectives of the PCGC are to identify genetic causes of human congenital heart disease and to relate genetic variants present in the congenital heart disease patient population to clinical outcomes. The CDDRC will expand the use of data previously generated by the B2B Cardiovascular Development Consortium (CvDC) to a broader number of data scientists by assembling the data into a queryable data repository complete with computational tools. The Administrative Coordinating Center (ACC) provides the infrastructure to enhance collaborations among the PCGC, CDDRC, and the PHN to identify and facilitate the translational research process for the most important pediatric cardiovascular clinical care problems. Our proposed ACC to support the PCGC and CDDRC is a unique, integrated combination of world-leading pediatric cardiovascular clinical/translational research expertise, advanced infrastructure, outstanding institutional support, and state-of-the-art technology. We believe these strengths to be critical for an ACC to successfully partner with the B2B program and NHLBI in leading the coordination of knowledge and data for this important pediatric cardiovascular research effort.